COVID Support from MGGM to NIAID Investigators

Transgenic animals: Using conventional transgenic approach, several transgenic lines were created for two independent projects, a) ACE2-GFP receptor and b) TMPRSS2 endothelial cell surface protein for Dr. Hickman. COVID-funding: A grant proposal submitted by MGGM was awarded $35,000 funding for the creation of humanized ACE2 NOD/ShiLtJ mice as model for underlying conditions in humans. Sperm Cryopreservation: Twelve sperm cryopreservation projects submitted during COVID-19 pandemic were successfully tested for QC by IVF followed by embryo transfer to the pseudo-pregnant mothers.